Functional characterization of clinically-identified coding variants in the transcription factor gene ZEB2

Project Summary/Abstract
Mutations in the ZEB2 transcription factor (TF) gene are the cause of Mowat-Wilson syndrome (MOWS), an
intellectual and developmental disability (IDD). While MOWS is due primarily to large deletions or premature
stop codons in ZEB2, little is known about rare missense variants in the gene. To date, there has not been a
genome-wide identification of ZEB2 DNA binding sites and its target genes in IDD-relevant cells. This proposal
aims to fill this knowledge gap using modified protocols developed in the Myers Lab for chromatin
immunoprecipitation followed by high-throughput sequencing (ChIP-seq). The proposal applies these methods
to identify the wild-type (WT) ZEB2 binding sites in induced pluripotent stem cells (iPSCs) as well as in
neuronal cells differentiated from these iPSCs; these cell types are highly relevant for IDD research. The lab’s
recently published method for assaying missense variants in TF genes will be used to perform the experiment
for five clinically-identified variants across domains of the ZEB2 gene. Differential binding will be assessed in
these variant cells, as well as the genomic association sites for two essential cofactors for ZEB2: SMAD1 and
CTBP1. This information will further clarify both WT and mutant ZEB2 functional activity. Finally, analytical
methods will be used to establish likely target genes for ZEB2 regulatory activity, and RNA-seq will be
performed to measure gene expression, correlating differential expression in variant cell lines with differential
binding. This work will be highly impactful for ZEB2 and MOWS research and future clinical diagnoses and will
lay the foundation for potential therapeutic interventions.

Public health relevance
Project Narrative Mutations in the ZEB2 gene cause an intellectual and developmental disability, Mowat-Wilson syndrome, which is characterized by developmental delays, intellectual disabilities, and various physical malformations. This work will identify the primary functions of the ZEB2 protein in human cells that are relevant to neural development and illuminate the impacts of gene changes found in children suffering from the disorder. The knowledge gained from the proposed work will inform future research, including diagnoses and potential therapeutic interventions.